INFLUENCE OF HEART RATE ON THE BOLD SIGNAL

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We have focused on methods for improving the sensitivity of BOLD fMRI time series analysis, specifically by modeling and reducing non-neural physiological confounds.